INTENSIVE NEURODIAGNOSTIC MONITORING IN PEDIATRIC EPILEPSY

Intensive neurodiagnostic (video, EEG, polygraphic) monitoring is being systemically studied to determine their effectiveness in the diagnosis and treatment of children with suspected epilepsy. (This is an ongoing study.)